Characterizing the GTPase activity of a novel contractile ring protein in Plasmodium falciparum

Plasmodium falciparum is a parasite with great public health importance as the deadliest causative agent of
malaria. The parasite has a complex life cycle, that requires a human and mosquito host. The clinical symptoms
associated with malaria are caused by the asexual blood stage which undergoes a divergent form of cell division
called schizogony. During schizogony, the parasite develops in a red blood cell (RBC) for 48 hours to generate
enough copies of every organelle to create 20-36 daughter cells in a single shared cytoplasm. The final step of
schizogony is segmentation, the synchronous cytokinesis event that creates dozens of daughter cells with high
fidelity. Segmentation is mainly driven by the basal complex, the putative contractile ring. The basal complex is
a massive multiprotein complex essential for proper daughter cell formation. However, the exact mechanism of
the basal complex is still unknown, and few components of the complex have been characterized. CINCH is a
highly essential member of the basal complex that has been shown to possess GTPase activity. CINCH is
predicted to act as a dynamin-superfamily protein (DSP) which are large mechanochemical GTPases that are
often involved in membrane contraction and scission. This is the first member of the complex identified that could
clarify the energetic force generated by the putative contractile ring. I will further assess the GTPase activity of
CINCH in vitro with a sensitive fluorescence-based assay to evaluate optimal conditions for activity and test our
ability to inhibit CINCH with broad-spectrum inhibitors. All DSPs form homodimers to stabilize GTP hydrolysis.
DSPs involved in membrane contraction will additionally form large polymers and wrap around membranes. As
the DSPs hydrolyze GTP, conformational changes in the protein constrict the underlying membrane. Isolating
CINCH for in vitro experiments allows us to determine if it will form ring-like structures in the absence of other
basal complex components. I will assess the oligomeric state of CINCH with size-exclusion chromatography,
blue native gels, and negative stain electron microscopy. The structures CINCH forms in isolation will have
implications on the formation of the basal complex in the parasite and the mechanism of contraction. While
CINCH is highly essential for parasite survival, the GTPase activity has not yet been shown to be the essential
function of the protein. I will determine the essentiality and role of the GTPase activity of Cl NCH using an in trans
complementation system. I will generate and test 10 mutants I predict will interfere with the enzymatic activity of
CINCH with conditional knockdown systems commonly used in our lab. All mutants will be assessed for protein
expression levels, localization, and parasite viability. Any defects in the mutants will be further evaluated by
super-resolution microscopy to determine when the defect occurs during segmentation and to what severity.
Together, these experiments will expand our understanding of the contractile ring of Plasmodium by evaluating
the role of an essential member of the basal complex.

Public health relevance
PROJECT NARRATIVE The malaria parasite poses an immense global health burden, yet much remains unknown about its core biology. We have identified a protein essential for proper cell division and cytokinesis which are poorly understood processes in the parasite. We will investigate the functional role of this protein in vitro and in vivo to inform the development of future antimalarials.